PDGF-regulated stem cells and bone disease

The growth and healing ability of the skeleton is possible because postnatal skeletal stem cells (SSCs) contin-
ually generate bone-forming osteoblasts. Platelet-derived growth factor receptor β (PDGFRβ) is expressed on
SSCs and osteoblasts, but its functional roles have not been characterized in vivo. Recently, humans with
gain-of-function mutations in PDGFRB have been reported to exhibit skeletal disease involving progressive
bone loss or skeletal overgrowth during childhood or adolescence. However, the target cell type and molecular
mechanisms underlying PDGFRβ-driven skeletal disease are unknown. The applicant’s long-term goal is to
develop a mechanistic understanding of how the PDGF pathway regulates mesenchymal cell plasticity. Bone
forms because osteoblasts produce collagen-rich organic matrix called osteoid, which subsequently becomes
mineralized into bone. Defects in cell plasticity and collagen production may underlie bone diseases driven by
the PDGF pathway. Therefore, the specific objective in this proposal is to identify PDGF-regulated mecha-
nisms controlling SSCs and their contribution to skeletal disease. The hypothesis underlying this project is that
PDGFRβ regulates SSC proliferation and differentiation through the balance of downstream effectors of the
signal transducer and activator of transcription (STAT) family. Aim 1 will use an SSC-targeted Cre/lox ap-
proach to induce PDGFRβ activating mutations and combinatorial STAT deletions, and determine whether
STATs mediate bone disease in vivo. Primary SSCs derived from mutant mouse bones will be used to investi-
gate whether PDGFRβ-regulated STAT signaling regulates SSC self-renewal and differentiation in vitro or after
transplantation. As an alternative approach, PDGFRβ activating mutations will be targeted to chondrocytes.
Aim 2 will characterize new mouse models with the PDGFRβ activating mutations most commonly found in
Penttinen syndrome and Kosaki overgrowth syndrome, V665A and P584R, respectively. Aim 2 will also ex-
plore the benefits of kinase inhibitors for mice with gain-of-function PDGFRβ signaling. Aim 3 will study mice
with gain- and loss-of-function mutations in PDGFRβ to identify the processes by which PDGFRβ regulates
SSCs and their progeny during postnatal skeleton growth. Mutant cells will be fate mapped to determine how
different levels of PDGFRβ activity regulate proliferation, differentiation, and cell fate in vivo. This work is ex-
pected to define how the PDGFRβ signaling pathway mediates osteogenesis and how too much or too little
signaling generates diseases of the skeleton, which will point to novel therapeutic strategies and better ap-
proaches for bone repair. The results of these projects will significantly advance understanding of SSC regula-
tory mechanisms. Information about signaling pathways and cell types that mediate disease-associated PDG-
FRβ signaling will inform the development of new therapeutic approaches for skeletal diseases. And identifying
the specific role of PDGFRβ in bone growth will begin to establish it as a molecular target for therapy. All of this
information will improve the restoration of structure and function to diseased or damaged bones.

Public health relevance
Adult skeletal stem cells are crucial for bone growth and repair. The results of these projects will significantly advance our understanding of stem cell regulatory mechanisms in the skeleton, which will be significant to human health because it may open the way to modulate the PDGFRβ signaling pathway as a future treatment strategy for bone disease and regenerative medicine. !